AIDS Clinical Trials Group (ACTG) DMC Activities

PROJECT SUMMARY
The District of Columbia Clinical Trials Unit (DC CTU, 5UM1AI154466) works with the global clinical trials
collaborative network known as the Advancing Clinical Therapeutics Globally for HIV and Other Infectious
Diseases (ACTG). The purpose of this supplement is to provide support for data management leadership and
expertise at the ACTG Data Management Center (DMC) at Frontier Science & Technology Research
Foundation, Inc. (FSTRF) for the design of study data collection materials, ongoing data monitoring and
reporting, data management training and support, and preparation of data sets for analysis for the studies
undertaken by the ACTG at the DC CTU and other ACTG clinical research sites. This work is essential to the
CTU and the ACTG in maintaining excellence in the design, conduct, and analysis of ACTG studies, and
ensuring the safety of participants in these studies.

Public health relevance
NARRATIVE This supplement will support the data management leadership and expertise at the Advancing Clinical Therapeutics Globally for HIV and Other Infectious Diseases (ACTG) Data Management Center (DMC) for studies undertaken by the ACTG at the District of Columbia Clinical Trials Unit and other ACTG clinical research sites. This work is essential to the CTU and the ACTG in maintaining excellence in the design, conduct, and analysis of ACTG studies, and ensuring the safety of participants in these studies.